Role of Gut Microbiota in Bone Mass Heritability and Skeletal Response to PTH

SUMMARY
Low bone mineral density (BMD) is a key feature of osteoporosis that is caused by deficient skeletal
development and/or accelerated bone loss. Interestingly, there is a high degree of variation in BMD within
populations, with about half of the differences in BMD attributed to genetic factors. However, the remaining
causes of BMD variance within populations remain enigmatic. With the help of the Human Microbiome Project,
we now understand that the microbiome plays a critical role in health and wellness. Implicating the microbiome
as a regulator of BMD are established reports that mice raised in germ-free (GF) conditions have altered bone
density compared to conventional mice. A number of elements influence the composition of the microbiota,
including both genomic and non-genomic factors. Of the non-genomic factors, a recently realized prevalent
influence is cohabitation with family members, where microbes transfer horizontally between co-inhabitants, or
vertically from parent to offspring. These observations are the basis of our compelling hypothesis that the
microbiome is a non-genomic contributor to BMD heretability, which affects the efficiency of skeletal mass
development. Corroborating this hypothesis is our data showing that BMD levels, and the frequency of
osteoclastogenic Th17 cells differ between isogenic mice with varying microbiome compositions. Critically, we
also show that equalization of the microbiota by co-housing these mice balances the frequency of Th17 cells,
and balances the bone density between the two groups. In this proposal, we will identify how microbiome
diversity acquired following birth shapes BMD and skeletal mass acquisition. In Aim 1, we will determine the
contribution of gut microbiota to post-natal skeletal mass acquisition and peak bone density. Here, we will
leverage gnotobiotic and immunological approaches extending a proven transdisciplinary partnership to
interrogate precisely controlled models of early-life intestinal microbial succession, to establish the role of the
maternal microbiome in transmitting the effects of the pre-natal microbiome to offspring. In Aim 2 we will
identify the role of gut bacterial activation of Th17 cells on post-natal skeletal development. Recent evidence
has shown that the gut microbiome plays a causal role in bone disease, where we reported that the
microbiome regulates the skeletal response to sex steroid deficiency. Our new preliminary data show that the
microbiome also influences the skeletal response to PTH, where we show that GF mice and antibiotic treated
conventional mice are resistant to the bone anabolic effects of PTH. Therefore, in Aim 3 we will identify the
functional elements within the gut microbiome and within the host that are necessary for PTH to exert its
modulatory effects on skeletal homeostasis. Understanding how the gut microbiome regulates skeletal mass
acquisition and the skeletal effects of PTH would potentially enable trials of rational manipulation of the early
life microbiota to remove microbial impediments to childhood skeletal mass acquisition, thereby facilitating
optimal skeletal mass development within the American populace.

Public health relevance
Role of gut microbiota in bone mass heritability and skeletal response to PTH Project Narrative This project will determine the contribution of the gut microbiome to the non-genomic heritability of bone mineral density. It will also determine the role of the microbiota in the mechanism of action of parathyroid hormone in bone. This may lead to new strategies for increasing bone mass in growing children.